Integration of an opioid dispensing, monitoring, and disposal platform with a hospital pharmacy to reduce opioid use by discharged emergency department patients

SUMMARY
Addinex is seeking to file for a new patent and trademarks to help commercialize our product.
Patent: Addinex’s IP attorney will ascertain the patentability of our invention, including showing that it is useful,
innovative, novel, and non-obvious, create, document, and file all applicable application documents, including
descriptions, claims, drawings, and other forms, perform patent research, both in the United States and in foreign
countries, regarding the existence of potential patent infringements, file the provisional patent application, and
deal with USPTO examiners during the application examination process.
Trademark: Addinex’s IP attorney will search for similar trademarks that could prevent ours from being registered
or used in commerce, interpret the results of such findings and advise us on how to proceed, evaluate the
strength of our proposed mark and help us develop a strong mark, explain our rights concerning the registered
mark and how to pursue infringement claims, prepare and file the trademark application and follow it throughout
the process should it require amendment, follow up on the process, adhere to deadlines, check status, and
respond to any further inquiries regarding our application.
Timeline and Milestones:
We plan to file both our new provisional patent and trademarks by year-end. With both in place, our products
and brand will be more protected as we transition to commercializing our product and speak with investors.

Public health relevance
NARRATIVE While Addinex’s existing individual dose medication dispenser is patented, there are situations when the pharmacy is not allowed to open the medication bottle to distribute the pills in the dispenser. Therefore, Addinex has recently developed an alternative version of our dispenser for these situations and is seeking to apply for a provisional patent to be able to use the new dispenser, if needed. In addition, we are seeking to trademark the Addinex name, logo, and mascot to protect our brand and reputation.